Racial and Geographic Disparities in Risk and Survival of Alzheimer's Disease and Related Dementias

Abstract
There exists a limited number of studies that assess health disparities in Alzheimer’s Disease (AD) and even
fewer for non-AD dementias. Insight from existing literature and our preliminary studies suggest that the most
essential health disparities in Alzheimer’s disease (AD) and related dementias (ADRD) are related to
race/ethnicity effects in AD risk and strong geographic gradient in mortality from AD. Our preliminary studies
showed significant gaps between incidence rates for different race groups and mortality rates between East and
West coast populations. In addition less significant disparities related to effects in rural/urban subpopulations
and differences in survival from AD/ADRD were also identified. Detailed epidemiologic descriptions of these
disparities, especially incorporating subgroups of AD-related dementias (ADRD), are lacking and the role of
behavioral factors, comorbidity, time-dependent cognitive trajectories, and genetic effects in the developments
of AD/ADRD are not sufficiently evaluated. Thus, there is a critical need to quantitatively describe the persistent
disparities in the AD/ADRD outcomes and clarify the role of the multiple contributing factors. Our preliminary
studies proved the ability to extract high-quality measures of the factors to be studied from the three datasets to
be used in this study: 5%-Medicare, HRS-Medicare, and SEER-Medicare as well as Multiple Cause of Death
database. Research in the project will be focused on i) re-evaluation of the disparities by calculating them with
better accuracy and addressing limitations of our preliminary analyses, ii) multiple analyses designed to explain
these disparities by analyzing the effects of potential mediators, iii) incorporating recent advanced
methodological approaches such as a new partitioning approach for the decomposition of an overall trend into
its causal components for analyses of these disparities in high volume data, and iv) incorporating new concepts
for the explanation of these disparities, such as the contribution of over/underdiagnoses, heterogeneity in
disease severity at time of diagnosis, analyses of patterns of conditions related to AD and ADRD, and the
contribution of AD resilience to these disparities. Four Specific Aims planned in this study will deal with i)
epidemiology of AD/ADRD, ii) behavior factors and comorbidity, iii) cognitive status and the effects of diagnosis
severity and over/under diagnosis, and iv) genetic effects and cognitive resilience. The completion of these Aims
will results not only in robust estimates of the disparities in AD/ADRD outcomes in diverse populations, but also,
ultimately results in improvements in public health that can be achieved through reducing the identified disparities
in AD/ADRD using targeted information based on the in-depth analyses conducted in this project. The expected
outcome will be detailed disease-specific information presented in a quantitative form that provides the
contribution of each studied factor to race/income-related health disparities in U.S. older adults. We will uncover
the barriers in health-care provision that can be further used for improving primary, secondary, and tertiary
prevention in the U.S. resulting, in their turn, in improved survival and higher life span.

Public health relevance
Narrative The processes causing the disparities in health outcomes in Alzheimer’s disease and related dementias are not well investigated. The objective of this study is to provide a series of estimates characterizing the effects of specific variables that explain the relationship between population groups and differences in health outcomes. The results of the study will uncover barriers in health-care provision the removal of which will aid in the development of public health interventions and improvements in preventive care for these serious health conditions ultimately leading to improved longevity in the U.S.